New York Consortium for Interdisciplinary Training in Kidney, Urological and Hematological Research (NYC Train KUHR)

Abstract
In this proposal we will use the new NIDDK Institutional Network Award (U2C/TL1) to develop a training
program in kidney, urologic or hematologic (KUH) research that differs from the traditional approach of
specialization in one of these disciplines by creating a dynamic, interdisciplinary KUH training program. Our
overarching goal is to provide an educational environment that fosters the development of a new cadre of KUH
investigators with a broad-based, interdisciplinary understanding of KUH research.
To achieve this goal, we propose the development of a “New York Consortium for Interdisciplinary
Training in Kidney, Urological and Hematological Research”, the “NYC Train KUHR”. This training program will
bring together investigators from four of the leading medical schools in the NYC metropolitan area; the Albert
Einstein College of Medicine, the Columbia University Irving Medical Center, the Icahn School of Medicine at
Mount Sinai and the Renaissance School of Medicine at Stony Brook University. The NYC Train KUHR will
include over 100 preceptors across the four institutions with varied and complementary research expertise,
thereby breaking down traditional silos that exist between the KUH disciplines and institutions. At full capacity
the consortium will train 9 pre-doctoral and 16 post-doctoral trainees. The training is supported by 4 Cores: the
Administrative, Professional Development, Networking and Training Cores. The Administrative Core will include
a 3 Core Leaders, a Director of Recruitment and Admissions, a Pilot Projects Program Coordinator, a Diversity
Officer, a Wellness Officer, a Program Evaluator and an administrator and administrative assistant to support
the missions of NYC Train KUHR. The Administrative Core will use frequent communication to achieve its goals
including facilitate monthly meetings of the Executive Committee and meetings of the other Committees.
The Administrative Core’s Specific Aims are to (1) support the leadership team and missions of the NYC
Train KUHR Networking, Professional Development and Training Cores; (2) organize and support the meetings
and work of the committees supporting the missions of the NYC Train KUHR program; (3) maintain a robust
evaluation program that fosters the continuous improvement of the Cores; (4) organize and manage an
intramural NYC Train KUHR pilot project award program to incentivize interdisciplinary collaborations, and (5)
organize an annual meeting between all awardees across the United States that are funded by NIDDK U2C/TL1
awards, with the goal to further promote interdisciplinary interactions and networking among all KUH trainees.
The national meeting will include research presentations by trainees and multiple networking and professional
development opportunities. This Administrative Core will provide the support necessary for NYC Train KUHR to
provide outstanding and innovative interdisciplinary training in KUH research.

Public health relevance
Project Narrative Not Applicable – Administrative Core